Applying deep learning to predict T cell receptor binding specificity of neoantigens and response to checkpoint inhibitors

Project Summary
Background: In-depth study of neoantigens will promote our knowledge of the fundamental mechanisms of
basic immunology and immune-related disease processes, such as response to cancer immunotherapy.
Neoantigens play a key role in the recognition of tumor cells by T cells and are increasingly shown to be
targets of checkpoint inhibitor-induced immune response. However, several missing links exist in neoantigen
research. (1) Only a small proportion of neoantigens can elicit T cell responses. It is even less clear which
neoantigens will be recognized by which specific T cell receptor (TCR). (2) Although neoantigens are important
during the course of action of immunotherapies, how neoantigen repertoire data can be used to predict patient
response is only poorly understood. (3) The lack of standardized analysis pipelines and limited sharing of
neoantigen data have hindered efficient and consistent research in the tumor immunogenomics field.
Aim 1: Build a transfer learning-based model to predict immunogenicity of neoantigens. So far, only a very
limited number of reports have created predictive models determining whether a neoantigen/MHC complex can
elicit any T cell response. Even fewer of them are capable of predicting the TCR-binding specificity of
neoantigens. However, the capability to predict the overall immunogenicity and the TCR-binding specificity of
neoantigens is critical for improving the benefit of immunotherapy. Aim 1 addresses this challenge with
advanced transfer learning algorithms, followed by benchmarking and laboratory validations.
Aim 2: Predict response to checkpoint inhibitors by integration of the immunogenicity and other properties of
all neoantigens in a patient, through a Bayesian multi-instance learning model. To date, most studies have
focused on the neoantigen/mutation load approach in correlation with response of patients to immunotherapy
administration. This simplistic approach misses the rich information contained in the whole repertoire of
neoantigens per patient and has been successful in only a few studies, but not others. Aim 2 addresses this
important inadequacy by creating a Bayesian multi-instance learning model that fully considers various quality
features, including immunogenicity, of all neoantigens in a patient for prediction of treatment response.
Aim 3: Create a web portal to provide neoantigen-related computational services and to share neoantigen
data. The PI will establish a public webserver providing cloud-based standardized services, including prediction
of neoantigens and the advanced analysis methods developed in Aim 1 and 2. The webserver will openly
share neoantigen/TCR and patient phenotype data, in accordance with IRB and HIPAA regulations.
Expected impact: (1) This project will predict the immunogenicity of neoantigens, which could inform
neoantigen vaccine development. (2) This project will predict response to checkpoint inhibitors and other forms
of immunotherapy based on patient neoantigen profiles. (3) The neoantigen database will propel research and
also lead to clinical applications for cancers and other immune-related diseases, such as COVID-19.

Public health relevance
Project Narrative We will develop deep learning-based models to predict the TCR binding specificity of neoantigens/MHC complexes (immunogenicity). We will predict patient response to checkpoint inhibitors and other forms of immunotherapy based on immunogenicity and other properties of neoantigens. We will build a comprehensive neoantigen webserver, which will facilitate a coordinated effort to accelerate tumor immunogenomics research and clinical applications for personalized medicine.